Variant Determinants of African American Limb Pathology in Peripheral Arterial Disease

Abstract
Peripheral artery disease (PAD) is caused by atherosclerosis of the peripheral arteries, most commonly in the
lower extremities, and affects 8-12 million individuals in the U.S. Cilastozol was the last drug approved to treat
patients with PAD (1999) and twenty years of trials and pre-clinical testing have failed to advance therapeutics.
PAD presents as either intermittent claudication (IC; pain with exertion that is relieved with rest) or critical limb
ischemia (CLI; pain at rest with or without tissue necrosis or gangrene). Although less common than IC, CLI
carries a substantially higher morbidity and mortality; CLI patients have a risk of major amputation or death that
approaches 40% in one year. Differences in the clinical course of IC and CLI together with results of recent pre-
clinical studies raise the intriguing possibility that IC and CLI represent distinct phenotypic manifestations of the
same disease process. We propose an innovative idea; regenerating and functionally competent skeletal muscle
supports ischemic neovascularization and vessel maturation - ultimately leading to the recovery of tissue blood
flow and the prevention of tissue loss. Our proposal will directly test the ability of ischemic cells in the local limb
microenvironment to alter tissue outcomes. We will interrogate the role of human BAG3 (Bcl-2 associated
athanogene 3 - an evolutionarily conserved 575 amino acid protein) specifically in the limb muscle and
endothelial cells of patients and mice. BAG3 is a multifunctional scaffolding protein and co-chaperone with
pleiotropic effects in heart and skeletal muscle. It is a promising genetic candidate for therapeutic development
in PAD for the following reasons: 1) mutations in BAG3 cause muscle myofibrillar myopathy and dilated
cardiomyopathy in humans, 2) BAG3 variants exist in both African Americans with CLI (a demographic
disproportionately affected by PAD - Preliminary Data) and cardiomyopathy, and 3) a murine coding variant in
BAG3 regulates muscle regeneration, vascular density, and limb survival in a pre-clinical model of PAD (hindlimb
ischemia-HLI). To that end, this proposal brings together clinical vascular surgeons, a skeletal muscle biologist
who focuses on physiologic outcome measures, a biochemist and mitochondrial biologist who focuses on
interrogating mitochondrial form and function in disease, a clinical cardiologist and researcher, and a translational
scientist who studies skeletal muscle adaptability to injury and endothelial cell biology and has developed an
unparalleled biobank of human PAD tissues. The central hypothesis of this proposal states that genetic
variants in BAG3 result in myopathy and mitochondriopathy that disrupts communication between
muscle and endothelial cells and results in a local muscle environment insufficient to support the
vasculature. To that end, the Specific Aims are: 1) In PAD relevant models, determine the functional link
between ischemic myopathy and angiogenesis. 2) Determine whether Cox6a2 expression is sufficient to rescue
BAG3 variant induced myopathy in PAD conditions. 3) Establish whether BAG3 variants are a link between AA
race and differences in CLI patient outcomes.

Public health relevance
Project Narrative – Public Health Relevance Peripheral arterial disease (PAD) is caused by atherosclerosis in the legs where blood flow is restricted. The central focus of PAD research for decades has been to understand and alter endothelial cell biology, yet no progress has been made towards effective therapeutic design. We will combine our use of innovative mouse genetic models, established PAD relevant laboratory models, innovative tools (gene therapy designed expression viruses), and a heterogeneous PAD patient population to fully interrogate the role of BAG3 as both a potential cause of pathology (in the case of the variants pre-disposing African Americans to severe disease outcomes) and as a potential target for therapeutic development.